DNA CONTENT OF DYSPLASTIC LESIONS IN HUMAN AND RAT LIVER

In preliminary experiments, it has been observed by cytospectrophotometric methods that a small number of nodules, induced in rat livers by an induction-promotion regimen, have an aneuploid modal DNA content. Since aneuploidy is associated with tumor progression, it is likely that its presence constitutes a "risk factor" for those nodules where it appears. There is no data available on nuclear DNA content in "liver cell dysplasia," a lesion in humans which is analogous to the rodent liver nodule. It is proposed to examine liver nodules induced in rats as before, using cytospectrophotometric and histochemical methods, to determine: a) if aneuploidy is associated with either partial hepatectomy, initiation, or initiation and promotion; b) the proportion of hepatomas with aneuploid pattern generated; c) the comparative effects of "stop experiments" and continuous promotion on aneuploid nodules; and d) the possible correspondence between aneuploidy and persistence or remodelling of the nodules. It is further proposed that aneuploidy is a "risk factor" for malignant transformation; this hypothesis will be tested by statistical analysis of data obtained and by intrasplenic transplantation of preneoplastic nodules. The likelihood that human liver cell dysplasia is a premalignant condition akin to some rat liver nodules will also be evaluated in autopsy cases with liver cirrhosis and/or hepatoma, by cytospectrophotometric detection of possible aneuploid modal DNA distribution. The experiments proposed may lead to: a) future exploration of possible mechanisms resulting in the aneuploid nuclear DNA content; b) less restrictive but more veritable regulations for in vivo tests of hepatocarcinogenesis; and c) improved prognostic value of liver biopsies, regarding the probability of hepatoma in human patients with liver cirrhosis.